Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE (AC)
The Administrative Core (AC) of the New Mexico Alzheimer’s Disease Research Center (NM ADRC) coordinates
all activities and ensures the cohesiveness of the 7 cores and one component. Individuals in the AC have been
working together in the exploratory NMeADRC. The AC formed critical partnerships to improve dementia
diagnosis and care in the urban and rural Hispanic/Latino (H/L) and American Indian (AI) communities. Zuni
Pueblo is an example of a rural medically underrepresented population a long distance from a major medical
center. We overcame the barriers of distance by using a mobile scanner to perform on-site MRI studies and with
Community Health Representative doing neuropsychological testing. We formed a partnership with the New
Mexico state Aging and Long-Term Services Department to expand dementia care by training community based
social workers with ECHO telehealth resources. Those identified as at risk for AD will undergo further studies at
the UNM Center for Memory and Aging (CMA). The AC will establish committees and hold regular meetings of
the Executive Committee composed of the Core leaders to address problems. We will continue to send
demographic, clinical, biomarker and imaging data to the national repositories. Training the next generation of
AD scientists will be done with developmental grants that will be awarded to two early-stage investigators. The
AC formed partnerships with other research centers in the university and around the state to promote AD/ADRD
research. The AC organized a highly successful research symposium that highlighted research at NM ADRC
and other sites. The AC was important in developing the framework for the P30 grant and identifying strong core
leaders from other departments in the university. The day-to-day operation of the NM ADRC will be done by the
AC in consultation with the core leaders. The University is committed to inclusiveness and diversity, and we will
conform to that model to aid the unique minoritized populations in the state. New Mexico is a “frontier” state with
a large land mass and a sparse, scattered population. The UNM CMA is the only center for dementia care in the
Rocky Mountain region and the NM ADRC will be the first such center in an area extending from Mexico to
Canada. It will bring advanced dementia research, such as plasma-based biomarkers and advanced MR imaging
to rural areas to identify individuals at risk for AD who could benefit from the emerging treatments for dementia.
The AC will oversee research in the NM ADRC on the role of inflammation and patient classification methods
based on machine learning, starting to bring concepts of precision medicine to rural communities.